Role of rRNA-derived short non-coding RNAs in innate immune response

Project Summary and Abstract
Infection of microbes causes a wide range of symptoms and diseases. Sustained efforts to understand the
mechanism of cellular defense systems against microbe infections are essential to develop effective prevention
methods and therapeutic applications. The innate immune system deploys various pattern-recognition receptors,
including Toll-like receptors (TLRs), to recognize the invasion of microbes and initiate protective responses.
TLRs are expressed at the cell surface or intracellular compartments (e.g., endosome and lysosome) in various
cell types, such as macrophages, and recognize pathogen-associated molecular patterns (PAMPs) such as
lipopolysaccharide (LPS) and peptidoglycan (PGN). The PAMP recognition initiates signal transduction
pathways that culminate in the activation of transcription factors such as NF-B, resulting in production of
cytokines and chemokines to protect the host. Following transcriptional regulation, the downstream of TLR
pathways involves regulation at multiple levels including post-transcription steps. In this context, short non-
coding RNAs (ncRNAs) have evolved as key post-transcriptional regulators. Among various short ncRNA
species, those from ribosomal RNAs (rRNAs), termed rRNA fragments (rRFs), are the most abundant class of
short ncRNAs and have recently gained increasing attentions on their expression and functional significance.
rRFs are constitutively expressed in multiple organisms including humans, and their expression is involved in
regulation of cell cycle and proliferation, apoptosis, and lipid and glucose metabolism. In humans, their
expression is modulated in a sex- and population-specific manner, and associated with type 2 diabetes and other
diseases. We propose that rRFs play important roles in innate immune response. In preliminary studies, we
found that the expression of rRFs is upregulated by the activation of surface TLR in human monocyte-derived
macrophages (HMDMs). Importantly, short ncRNA sequencing data demonstrated the abundant accumulation
of the rRFs not only in HMDMs but also in their secreted extracellular vehicles (EVs). Further experiments
showed that a specific extracellular rRF activates endosomal TLR in the recipient HMDMs to induce cytokine
secretion, suggesting that rRFs are not just accumulated as degradation by-products of rRNAs, but are
accumulated as functional molecules promoting immune response. In the proposed studies, we will identify the
expression profiles of TLR pathway-induced rRFs in HMDMs and their EVs (Aim 1). We will further elucidate the
molecular function of extracellular rRFs in endosomal TLR activation (Aim 2). Finally, we will characterize the
rRF expression in plasma samples from healthy subjects and patients infected with Mycobacterium tuberculosis
(Aim 3). By defining a novel class of TLR pathway-induced rRFs and further establishing their roles, our study
will reveal a novel rRNA-engaged ncRNA pathway in the innate immune response and may support the future
exploration of biomarkers and efficacious therapeutic applications targeting ncRNAs upon microbe infection.

Public health relevance
Project Narrative The innate immune system deploys various pattern-recognition receptors, including Toll-like receptors (TLRs), to detect the infection of pathogenic microbes and initiate protective responses. We recently discovered ribosomal RNA (rRNA)-derived non-coding RNAs (ncRNAs) which are abundantly accumulated upon activation of TLR pathways in macrophages and their extracellular vehicles (EVs). The goal of the proposed project is to characterize the expression profile and molecular function of the TLR pathway-induced rRNA-derived ncRNAs in human macrophages and their EVs, which will represent novel research efforts to clarify rRNA-engaged pathway in the immune response and may support future exploration of biomarkers and efficacious therapeutic applications targeting the rRNA-derived ncRNAs in microbe infection.